PHENOTYPE/GENOTYPE CORRELATIONS FOR CONTIGUOUS GENE DELETION SYNDROMES

In this protocol, phenotypic characterization and systematic evaluation of specific organ system development are correlated with ongoing molecular analysis of contiguous gene syndromes in patients having Williams Syndrome, Smith-Magenis Syndrome, Prader-Willi Syndrome and DiGeorge/Velo-Cardio-Facial Syndrome.